The impact of obesity on cerebral glucose transport and metabolism

Project summary
There is a growing body of evidence that obesity is associated with reduced cerebral metabolism; however, the
underlying mechanisms and the functional clinical implications of these observations remain unclear. The
central goal of this project is to investigate a finding we have recently made that obesity is associated with
decreased transport capacity for glucose across the blood-brain barrier. Furthermore, this association may be
mediated by circulating fatty acids. This proposal uses state of the art neuroimaging technology coupled with
classic human metabolic phenotyping methodologies to investigate the underlying mechanisms behind how the
brain is impacted by obesity. Aim 1 of this project will determine whether obesity is associated with changes in
brain glucose transport and metabolism using 13C magnetic resonance spectroscopy scanning. Aim 2 of this
project will use a randomized controlled study design to assess whether acute elevations of circulating fatty
acid levels amongst lean, healthy control subjects will lead to decreased brain glucose levels. Finally, Aim 3 of
this project will use parallel studies using a rat model to investigate the underlying cellular mechanisms.
Because the brain is exquisitely sensitive to circulating glucose levels, the findings from this proposed study
will help clarify how diminished brain glucose transport in obesity may lead to diminished post-prandial satiety
signaling and/or be a potential mechanism for the neurocognitive consequences of obesity.

Public health relevance
Project Narrative The majority of people in the US are overweight or obese and the lack of effective, long-term treatment options lends a particular urgency towards understanding the underlying physiologic mechanisms driving obesity. The purpose of these human and rodent studies are to investigate the impact of obesity and increased circulating fatty acid levels on the brain. The proposed studies in this R01 proposal will lay the foundation for future studies targeting brain glucose transport and metabolism alterations to treat and prevent the central nervous system complications of obesity.